2025 Cancer Nanotechnology Gordon Research Conference and Gordon Research Seminar

Project Abstract
The objectives of the Cancer Nanotechnology Gordon Research Conference (CN-GRC) are to: 1) bring together
internationally renowned experts and young scientists to discuss groundbreaking discoveries in research,
diagnosis, and treatment of cancer using nanotechnology; 2) highlight developments and opportunities for
advancing nanomedicine technology to the marketplace; and 3) engage and educate a diverse group of students,
postdoctoral trainees, and scientists from around the world. The target audience includes chemists, biologists,
physicists, engineers, clinicians, and regulatory scientists from academia, industry, and government who employ
nanotechnology for the treatment and diagnosis of cancer. Graduate students and postdocs comprise an
important proportion of attendees, so the Cancer Nanotechnology Gordon Research Symposium (CN-GRS) was
established as a dedicated forum for junior researchers, which will enhance the participation of young scientists
at the upcoming conference. To address innovative developments and emerging trends in Cancer Nanomedicine
the overall theme of the 2025 CN-GRC is “Nanoscale Discoveries to Transform Clinical Outcomes.” The
meeting will include forward-looking sessions on the frontiers of cancer nanotechnology, including sessions
focused on developing personalized nanomedicines for clinical translation, improving early diagnosis, and
building new research tools to make novel discoveries. Revolutionary advances in cancer nanotechnology
require collaboration among researchers working in diverse fields including materials science, chemistry,
imaging, cell biology, tissue engineering, drug, and gene delivery, as well as clinical research. This meeting is
unique because it provides a relatively small and focused venue for researchers to get to know each other
personally and professionally, yet large enough for a comprehensive discussion of scientific, translational, and
clinical aspects. The GRC format and spirit are well-suited to the interdisciplinary nature of cancer
nanotechnology research, including the tradition of sharing unpublished data discussing emerging scientific
questions, an environment that supports informal discussions, a longstanding custom of excellent interactions
across all levels of seniority, from new students to world-renowned PIs, a mentoring component within the CN-
GRS, active participation and an exceptional training environment for students and postdocs through the CN-
GRS and short talks at the CN-GRC. The PIs include CN-GRC chairs, vice chairs, and CN-GRS chairs with
substantial experience in cancer nanotechnology research, conference organization, and mentoring. This
proposal requests funding for the 2025 CN-GRC and accompanying CN-GRS to enhance the participation of
junior and underrepresented scientists. Our specific aims are to: 1) Bring together highly qualified, world-
renowned speakers to share cutting-edge research in cancer nanotechnology, 2) Foster discussion, exchange
of ideas, and promote collaborations, and 3) Enhance the training and development of young scientists and
promote diversity.

Public health relevance
Project Narrative The 2025 Cancer Nanotechnology Gordon Research Conference and accompanying Gordon Research Seminar (a dedicated forum for junior researchers) will bring together scientists from diverse backgrounds, career stages (from world-renowned topical experts to junior trainees), and industries (including academia, industry, government, and healthcare) to discuss challenges and opportunities related to the use of nanotechnologies for the detection, treatment, and study of cancer. The meeting theme is “Nanoscale Discoveries to Transform Clinical Outcomes” and will include forward-looking sessions focused on overcoming biological barriers to cancer nanomedicine, using artificial intelligence approaches to advance cancer nanotechnology, and developing personalized treatments, accurate diagnostics, and novel research tools. Additionally, informal mentoring sessions and discussions will enhance the training and development of young scientists, promote diversity in the field, and prepare the next generation of cancer nanotechnology researchers to tackle emerging scientific questions.